GLYCOSIDASES IN HUMAN HEALTH AND DISEASE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We have been studying the structures and functions of glycoside hydrolases involved in human health and disease. Golgi alpha-mannosidase II is at the core of the mammalian N-glycosylation pathway, and is an anti-metastatic target. We plan to collect some complexes with novel inhibitors that have been developed based on our structural results (some of which were from CHESS data). Maltase glucoamylase is an important enzyme in intestinal starch digestion and a target for anti-diabetics. We solved the structure with CHESS data and are now collecting novel inhibitor complexes and attempting to improve the resolution. Finally, a-glucosidase I is the first enzyme in the protein folding `quality control` pathway. This is a new structure and we wil be collecting native data and possibly derivative (halide soak) data.